Informal Caregiving Networks of Older Adults with Dementia

ABSTRACT
In 2021, approximately 11 million Americans provided unpaid care to an adult with Alzheimer’s disease and
related dementias (ADRD), which was estimated to be 16 billion hours of assistance valued at $271.6 billion.
Over 65% of older adults with dementia in the community rely on 2 or more family members or friends to meet
their needs, ranging from basic activities of daily living to self-care activities and care decisions. Yet, most
caregiving research has been focused on the roles and care burden, including psychosocial and physical
health, of a single primary caregiver. Given the aging of the population and the changing demographics of what
constitutes a caregiver or care partner in the context of ADRD, the study of caregiving needs to expand to
consider the substantial collaboration and co-management that comprises present day caregiving. Our recent
study to evaluate the scope and potential impact of informal caregiving networks for older persons with
dementia (PWD), using an egocentric social network approach, i.e., based on the informant’s perspective,
revealed that there are complex group dynamics and allocation of care activities, including financial obligation,
among multiple members of a caregiving network. It also revealed the potential impact of these caregiving
networks such that the outcomes of caregivers (e.g., financial hardship) and PWD (e.g., hospital admissions)
may be affected by the characteristics of the caregiving network (e.g., member dynamics). In response to
NOT-AG-21-047, we propose a longitudinal social network study to capture networks of informal caregiving for
408 PWD and assess the impact of caregiving network characteristics on caregivers’ and PWDs’ health and
wellbeing, particularly with regard to the role of social interactions and group dynamics. We will include up to 3
family caregiver informants per network using a multi-informant approach. We estimate that the study will
include ~894 family caregiver informants. We will use Social Vulnerability Index scores to ensure a racially and
socioeconomically diverse sample of PWD. We will characterize informal caregiving networks by describing
network properties (e.g., size, member connectivity), member composition, frequency and type of help the
members provide to the PWD, and level of caregiving role distribution. We will examine the extent of changes
in network characteristics over 2 years and the impact of the network properties on caregiver and PWD
outcomes. Caregiver outcomes will include overall self-rated health, ED visits and hospital admissions,
depression, caregiving burden, rewards of caregiving, and financial hardship. PWD outcomes will include ED
visits and hospital admissions, proxy-reported quality of life, and changes in living arrangements. Our results
will inform strategies for alleviating caregiver burden that take a network perspective into account, such as
supporting the community of informal caregivers rather than solely focusing on a primary caregiver
designation. New strategies would consider caregiving role distribution, network dynamics, and information and
resource sharing to improve the health outcomes of caregivers and PWD.

Public health relevance
PROJECT NARRATIVE Informal caregiving for persons with dementia (PWD) who are living at home typically involve multiple caregivers, but little is known about the full scope of caregiving experienced by the many family members and/or friends involved in caregiving for PWD in the community. The proposed research will for the first time characterize informal caregiving networks of PWD longitudinally and generate evidence on how the network characteristics affect caregivers and PWD outcomes to help identify strategies for alleviating caregiver burden.